Resource Core

Project Summary/Abstract Section – RESOURCE CORE
To organize unique resources most powerfully for our Core Center for Clinical Research (CCCR) and foster approaches to fill research gaps impeding the NIAMS mission to improve health, we propose a Resource Core, Community Engaged Assessment and Intervention Science and Technology in Daily Life (CE-ASSIST-Daily Life). We will catalyze growing awareness in our Research Community of the necessity of community engagement and will target investigators across the translational spectrum. We will improve efficiency by leveraging hubs of Northwestern University (NU) expertise. In turn, our Core will enrich these hubs’ activities by expanding their portfolios through our unique, content (NIAMS mission)-specific model of integrated activity. For research focused on persons with or at risk for rheumatic and musculoskeletal conditions, our aims are: 1) Create and sustain interaction between stakeholders and research teams through project stages, a) build pathways for bidirectional community↔academic exchange to increase research value for improving health by refining research ideas and planning in partnership, e.g., through our CCCR Community Advisory Board (CAB), including a community liaison on the Core team, organizing project-specific Stakeholder-Academic Resource Panels that bring investigators and stakeholders together to improve research relevance, team composition, design, implementation, and dissemination, b) build capacity for community-engaged research, e.g., by conducting academic and community outreach, providing training within CCCR educational activities, and giving feedback on enhancing community engagement to all CCCR users; 2) Help project teams design research that integrates personal and community perspectives, a) refine research questions, study design, assessment plan, intervention comparators and intervention procedures, and assist with budget planning, all in conjunction with the Methodologic Core, b) get stakeholder input on variables and outcomes that matter most to individuals and collaboratively develop assessment plans that can include determinants of health as well as self-report to assess social/physical/mental health, symptoms, and life satisfaction, performance-based assessment of motor/sensory/cognitive function, accelerometry to assess physical activity/sedentary behavior/sleep, mobile and sensor-based applications (e.g., GPS, activity logs) that identify behavioral markers, and wearable biosensors to predict physiological and psychological states; 3) Help project teams operationalize their research and create dissemination plans for the scientific community and stakeholders. Because this Core (a) is centered on our goal, to improve how persons feel and function in their daily lives, (b) focuses on community and personal experience, (c) builds upon the wearable and portable technology revolution, and (d) integrates outstanding hubs, CE-ASSIST-Daily Life is well-positioned to have substantial impact on work within and beyond our institution.